Net Worth Poverty and Children's Development

1 Project Summary (limit 30 lines)
2 In the United States, economic precarity for children has been narrowly defined in terms of
3 income poverty (IP), which overlooks the large share of children who are at risk because their
4 families are net worth poor. Net worth poverty (NWP) refers to households whose net worth
5 (assets less debts) is less than one-fourth of the federal poverty. NWP is pervasive among
6 households with children (child households), as 35% of child households were net worth poor in
7 2019, with higher fractions of NWP among African American (57%) and Hispanic (50%) child
8 households. Three-fourths of child households who are net worth poor are not income poor and
9 the associations between NWP and child developmental outcomes are unlikely to be
10 attributable to IP. We propose that a narrow focus on IP ignores the potential risk faced by
11 children who are net worth poor, overlooks how NWP contributes to racial and ethnic gaps in
12 child well-being, and that policies that are income-centric will be limited in their effectiveness if
13 they do not also address NWP. This innovative research seeks to: 1) identify if NWP is
14 associated with children's cognitive and behavioral outcomes, and if NWP operates
15 independently of IP; 2) investigate how racial and ethnic disparities in NWP are associated with
16 racial and ethnic disparities in children's cognitive and behavioral outcomes; and 3) examine
17 how the Earned Income Tax Credit (EITC) alleviates NWP and its attendant negative
18 consequences on child well-being. Data come from the 1994-2019 Panel Study of Income
19 Dynamics (PSID) and its Child Development Survey (CDSS). In addition to growth curve
20 models, the project employs two-stage least squares to produce quasi-experimental estimates
21 of the effect of EITC on NWP and child outcomes and Agent Based Models (ABMs), a
22 simulation modeling approach to explore “what if” scenarios. Models will be conducted
23 separately by child age to investigate if associations vary by developmental stage. This project
24 advances knowledge by analyzing the unique risks posed by wealth deprivation and evaluating
25 their consequences for the well-being of African American and Hispanic children. Our work also
26 lays the foundation for a randomized control trial that would test the NWP-reducing effects of
27 cash and asset transfers. In sum, we contribute social and policy knowledge to an overlooked
28 component of economic deprivation, delineate the potential consequence of wealth deprivation
29 for racial and ethnic gaps in child well-being and inform ongoing policy efforts as to how
30 economic-resource centered policies and practices can enhance the well-being of children.

Public health relevance
Project Narrative This innovative research examines how net worth poverty, distinct from income poverty, is associated with children’s cognitive and behavioral development. Our investigation contributes a new perspective on economic precarity of child households, on the ways in which wealth and income scarcity contribute to racial and ethnic gaps in child well-being, and on the role that anti-poverty policies play in supporting the overall economic health of child households.